Four-Dimensional Heterogeneity of Fluid Phase Biopsies in Cancer (4DB-Center)

DESCRIPTION (provided by applicant): The 4DB Center will be directed by the PI, Peter Kuhn (physics), who will be assisted by senior co-investigator Kelly Bethel (oncology). Both are voting members of the Center Advisory Committee (CAC) and will be joined by John Griffin (hematology) and Paul Newton (mathematics/physics). Along with four external scientific advisors as non-voting members and an NCI representative, they will oversee all programmatic and organizational aspects of the Center, its integration with the PS-OC Network and its education and outreach mission. An internal physics oncology interface board will provide additional guidance and institutional support. A key aspect of the CAC's responsibilities will be the development of pilot and trans-network projects to further the 4DB Center research goals as well as to complement the research of the other PS-OC Network centers. The project manager, Enrique Abola, will be responsible for the day-to-day center operations and will report to Drs. Kuhn and Bethel, who are responsible for communication and interaction with the PS-OCs Steering Committee (PSC). The 4DB Center data sharing and communication will be integrated through an enterprise-class software system consisting of a database system, web portal and standalone software programs for data/sample tracking and data annotation/collaboration.